Transcriptomic Entropy to Quantify Maturation of PSC-Derived Cardiomyocytes

PROJECT SUMMARY
The immaturity of pluripotent stem cell-derived cardiomyocytes (PSC-CMs) has emerged as a major challenge
for their broad applicability. For this reason, extensive biological and engineering efforts are underway with the
goal to generate mature, adult-like CMs from PSCs. However, owing to the lack of quantitative metrics to
benchmark the maturation status of PSC-CMs, the efforts are being made largely on an ad hoc basis, and this
leaves the degree and direction of PSC-CM maturation unclear. To address this, we have developed a
quantitative metric based on an entropy concept that enables cross-comparison studies robust to experimental
variability and species difference. With this finding, this proposal aims to apply entropy score to determine the
status and trajectory of PSC-CM maturation achieved by molecular stimulation, tissue engineering, and in vivo
transplantation, combined with functional and structural analysis. The use of entropy score is expected to reveal
strengths and weaknesses of the ongoing approaches and inform us potential causes of maturation arrest and
deviations. Thus, the proposed research will provide mechanistic insights into instructing PSC-CM to become
adult CMs as well as quantitative insights into the progress made towards PSC-CM maturation in the field.

Public health relevance
PROJECT NARRATIVE The lack of comprehensive metrics to determine the maturation status of pluripotent stem cell-derived cardiomyocytes (PSC-CMs) remains a key obstacle to assess the effects of ongoing efforts to mature PSC-CMs. We have developed a novel entropy-based metric that enables quantitative assessment of PSC-CM maturation, and this proposal focuses on using this metric to directly compare PSC-CMs matured by new and existing strategies with native CMs undergoing maturation. This will provide quantitative and mechanistic insights into generating mature adult CMs from PSCs.